Cryoprobe repairs and amplifier replacement for the 800 and 750 MHz spectrometers

Project Summary Overall The Overall section of the P41 presents a summary of the four TR&D projects which are part of the proposal. These include TR&D 1 ? New instrumentation for magnetic resonance TR&D 2 ? High-field and fast-MAS methods for biomolecular structure and dynamics TR&D 3 ? Next generation solution NMR methods TR&D 4 -- Advanced Magic Angle Spinning NMR methods The specific aims of each of these projects is described and a summary of the contents in presented in more detail. In addition, we provide a rationale for the P41 center which includes the cost and size of present day instrumentation, the unique requirements for instruments and the sophistication of magnetic resonance spectroscopy. We also provide a table enumerating the equipment presently available for the CMR and a list of the new instrumentation that will be constructed during the five years of the proposed grant.

Public health relevance
Narrative The proposal request funding to operate the MIT-Harvard Center for Magnetic Resonance located at the Francis Bitter Magnet Laboratory at MIT. The research encompasses new instrumentation for dynamic nuclear polarization experiments at high field, 2H and 19F MAS experiments to elucidate the structure of GPCR’s, advance solution NMR experiments and development of cryogenic recirculation equipment and diamond rotors for magic angle spinning in the 200-250 kHz regime. The technology is designed to satisfy the growing needs of a cohort of outstanding NMR spectroscopists who do not have access to the specialized equipment and to propagate rapidly to the larger scientific community.